Multimodal mapping of the human face perception

DESCRIPTION (provided by applicant): Magnetic resonance imaging (MRI) provides an unique combination of structural and functional information of the living brain non.invasively, thus yielding information about the where of the human brain's functional architecture. Such localization information alone however must leave pivotal questions about the "HOW" of the human brain's information processing obscured. The overall objective of this proposal is twofold. First, we aim to define a novel method for multimode mapping of the functional and "axonal" signatures of the brain's architecture. To this end, by taking advantage of the ultra-high field 7 Tesla magnet, we hypothesize that "Diffusion Tensor Imaging" (DTI) in combination with sub millimeter resolution functional MRI at 7 Tesla will provide the very first direct correspondences between the functional domains and the underlying neuronal circuitry in humans in vivo. This new method will then be used for the second aim. Here, high resolution Diffusion Tensor Imaging (DTI) will be acquired in conjunction with ultra-high resolution fMRI from the human ventral visual stream including the Fusiform Face Area (FFA). While FFA has been determined as the prime candidate or human face and complex object processing, the actual neural circuitry-giving rising to its computational capabilities remain elusive. We hypothesize that the combined use fMRI and DTI in 7 Tesla as proposed in this study will provide exceedingly fine grained correspondences between functional domains in human occipito-ventral areas and the underlying cortical circuitry. To this end, we specifically hypothesize that the "face" selective vowels in the human Fusiform Face Area (FFA) differ in their connectivity pattern to the rest of the ventral and/or dorsal visual pathway in comparison to the moonfaced selective voxels from the same area. This research network consists of investigators representing a vast range of research expertises including cognitive neuroimaging MR physics, visual neurosciences, computational neurosciences, and fMRI data processing.